Environmental Exposure and Cardiometabolic Disease

This proposal is to continue to grow and expand the University of Louisville Superfund
Center established in 2017. Currently, the Center supports research on the
cardiometabolic effects of volatile organic chemicals (VOCs) that are of high relevance
to the Superfund Program. Center investigators conduct mode-of-action research to
unravel critical pathways of toxicity and to identify toxicological endpoints
(cardiometabolic changes) of chemicals (VOCs) found at Superfund and related sites.
Using high throughput mass spectrometry and an innovative suite of mechanism-based
biomarkers, animal experiments and human population studies, Center investigations
have contributed to the discovery and validation of novel biomarkers of both exposure
and cardiometabolic injury that would lay the foundation for future remediation
strategies. These studies employ state-of-the-art tools to develop pollutant atmospheres
for animal exposure and to measure unique and sensitive biological endpoints reflective
of cardiometabolic injury. In addition, work supported by the Center is leading to the
development of new methods and devices for quantifying atmospheric levels of VOCs
that employ advanced technologies and offer precise, but low-cost measurements of
hazardous waste sites. As before, the major objectives of the Center are to conduct
state-of-the-art research on the cardiometabolic toxicity of VOCs and to determine how
they affect cardiometabolic disease (CMD) prevalence and severity in exposed
populations. These studies will be complemented by mode-of-action mechanistic studies
in animals to identify the molecular and cellular mechanisms that contribute to VOC
toxicity. The findings of these studies will continue to contribute to both the discovery
and the validation of sensitive and robust biomarkers that could be used to assess the
extent of exposure, metabolism and toxicity. Center investigators are creating new
technologies for detecting VOCs at low environmental levels to enable future exposure
assessment activities. Senior Center members educate and train junior investigators,
graduate students and post-doctoral Fellows in the field of environmental science and
promote relevant community awareness and participation to enhance mutual
bidirectional understanding of exposure risk and the health effects of exposure. The
findings and discoveries of the Center will be transferred to affected communities, end
users in public and private sectors, and other stakeholders. For future use and analysis,
all samples of human and animal tissues and all data collected during Center
investigations will be stored in a computer-coded biorepository. Collectively, expansion
and growth of the Center activities will enhance its contribution and lead to rigorous
evaluation and better understanding of the effects of these hazardous chemicals on
obesity, diabetes and cardiovascular disease.

Public health relevance
This proposal is to establish a Center to support research on the health effects of hazardous Superfund chemicals. Work in this Center will help in evaluating the health impacts of several hazardous chemicals that are present in the environment and in understanding how exposure to chemicals could contribute to the risk and development of obesity, diabetes and heart disease, which despite recent medical advances, remain the leading causes of death worldwide.